CE25-029 - A comprehensive strain-based approach to examine intimate partner violence-related firearm homicides of children as corollary victims

PROJECT SUMMARY
Efforts to prevent firearm homicide of children in the context of parental intimate partner violence (IPV) remain
limited. One in four U.S. children ages 0-17 is exposed to parental IPV, and their risk of death increases when
firearms are present at home. Prior studies often fail to distinguish children who are corollary homicide victims
as a specific group and have created a gap in addressing lethal risks. This K01 project aims to address this
gap by examining the underlying causes and determining child lethality risk assessment items for potential
intervention points to reduce IPV-related firearm child deaths. Guided by the General Strain Theory with the
CDC’s four-level social-ecological model, this approach aims to highlight the strain and stressors that high-risk
families face in their communities. Aim 1 will identify contextual typologies and investigate whether these
corollary child victims are a category with distinct subgroups, which aligns with the National Center for Injury
Prevention and Control (NCIPC) research priorities on firearm-related deaths among children and youth and
the identification and measurement of contextual typologies of adult IPV. Aim 2 aligns with the NCIPC’s
research priority to examine the relationship-level and community-level risk factors for adult IPV based on the
geographical distribution of IPV-related firearm homicides of children in two states. Aim 3 will create
measurable items to predict children’s lethal risk in addition to the existing risk assessments for IPV adult
survivors. Research outcomes will identify child-specific firearm-related risk factors that can be applied to
clinical and practice settings to reduce homicide and violence. The Career Development Plan includes
strategic objectives: 1) develop expertise in child-specific firearm-related IPV risk factors of homicides; 2) gain
mastery of advanced techniques to analyze homicide data; 3) apply social ecology to firearm violence
prevention. The strong mentoring team includes primary mentor Dr. Jill Messing, Professor and Director of
Gender-Based Violence at the School of Social Work at Arizona State University. Co-mentors are Dr.
Jacquelyn Campbell, Professor at Johns Hopkins University School of Nursing, and Dr. Lynn Addington,
Professor at the Department of Justice, Law & Criminology at American University. Training activities include
hands-on data analysis lessons with Dr. Messing, online and face-to-face courses in advanced statistics and
firearm prevention, and conferences and workshops hosted by the Homicide Research Working Group and the
Research Society for the Prevention of Firearm Harms. Research results will be disseminated through at least
three conference presentations and three first-authored manuscripts, as well as the submission of an R21 and
R01, or equivalent, grant proposal. The findings will be available to advocates and practitioners by developing
and disseminating research briefs with actionable recommendations to healthcare providers and state
stakeholders. Overall, the successful completion of this K01 project will lead to longer-term goals of
crosscutting violence prevention for a vulnerable population and a sustainable, independent research career.

Public health relevance
PROJECT NARRATIVE Children ages 0 and 17 exposed to family violence, especially in homes with firearms, are at higher risk of being killed; however, we do not have enough preventive strategies to protect the lives of IPV victims and children before individuals use available firearms and turn a heated argument into a deadly circumstance. This research will analyze data from national crime datasets on IPV and violent deaths and university studies on intimate partner homicide to determine multi-level, child-specific, and firearm-related risk factors, aiming to develop effective prevention strategies to protect children from potential violence and homicide. The project is endorsed by a strong mentor team with three well-established experts to assist an early-career investigator in developing analytical skills and gaining research independence in violence prevention research with a focus on preventing firearm homicide among children at home in the context of parental IPV.